New Statistical Methods for Modelling Cancer Outcomes

Project Summary/Abstract
The proposal addresses two pressing medical problems. First, opioid use is crucial for managing
pain in surgical and cancer patients, but over-prescription has led to a significant public health
crisis. Opioid overdose deaths have tripled in the past decade, with over half of these fatalities
linked to prescription opioids. The lack of reliable, data-driven guidelines has contributed to opioid
diversion and increased addiction risks among patients. Thus, there is an urgent need to forecast
opioid prescription quantities for surgical patients and measure the associated uncertainty to
establish better guidelines for opioid prescriptions. Second, lung cancer remains a major and
deadly threat, claiming approximately 150,000 lives annually in the United States, underscoring
the need for more effective intervention strategies. Recently, there has been growing interest in
understanding the implications of lung muscle metrics on lung cancer mortality. This effort has
the potential to lead to personalized interventions that encompass clinical, nutritional, and physical
aspects tailored to individual patient profiles.
The proposal is motivated by two large databases in which Principal Investigator Dr. Yi Li is
actively involved. First, the Michigan Surgical Quality Collaborative (MSQC) project includes data
from 21,033 opioid-naïve adult postoperative patients across 70 hospitals, capturing demographic,
perioperative, clinical, and mortality characteristics through postoperative surveys. Patients who
underwent surgery in Michigan between January 2017 and October 2019 were prescribed opioids
at discharge, with ongoing use or refill determined by their pain levels. Second, the Boston Lung
Cancer Survival Cohort (BLCSC) study, one of the largest lung cancer cohorts in the country, has
enrolled 12,951 lung cancer cases at Massachusetts General Hospital and Dana-Farber Cancer
Institute since 1992. It collects comprehensive demographic, smoking, and dietary information,
along with pathology, imaging, treatment details, oncogenic mutation status, serum, white blood
cells, germline DNA, and tumor tissues.
Leveraging these rich databases, we aim to develop new methods to predict and infer adverse
outcomes. We propose various methods to predict prescribed opioid dose levels post-surgery,
quantify the associated uncertainty, and analyze refill patterns for individual patients. Additionally,
we will develop methods to elucidate the impacts of lung muscle metrics on lung cancer mortality,
which could have significant interventional implications. In summary, these rich databases and
new methodologies will enable our findings to inform individual-based prescription guidelines,
detect new prognostic biomarkers and impact medical practice.

Public health relevance
Project Narrative The project tackles two critical medical issues. First, we propose various methods to predict prescribed opioid dose levels post-surgery, quantify the associated uncertainty, and analyze refill patterns for individual patients. Second, we develop a series of methods to elucidate the impacts of lung muscle metrics on lung cancer mortality, which could have interventional implications.